Administrative Core

ADMINISTRATIVE CORE SUMMARY
Through the direction and management efforts of the Administrative Core leadership and the Coordinators of
the associated Core activities, the Hawaii INBRE has effectively implemented successful programs focused on
research training, career development, and enhancement of investigators, postdoctoral fellows, and students
of the institutions involved in the network. A major goal has consistently been to facilitate effective growth and
development of the network and enhance diversity within the biomedical research workforce, and this will
continue to be our focus as we enter the next cycle of INBRE V. The Administrative Core will be led by an R1
institution, the University of Hawaii at Manoa (UH Manoa), and will work with the Internal Executive Committee
(IEC) and External Advisory Committee (EAC) along with the steering committee (SC) to effectively provide
advice and recommendations to the participating institutions in the network. The Administrative Core will
leverage the combined resources of the network to support the development of focused research investigators
at the primarily undergraduate institution (PUI) and community college (CC) partners, provide opportunities for
advanced undergraduate (UG) student research experiences (SRE) throughout the network, and support of a
state-of-the-art Data Sciences core to provide cutting-edge services to our INBRE students and investigators at
all stages of development. With its partner institutions located on three islands in the state of Hawaii, separated
by large distances and several time zones from the U.S. mainland, Hawaii INBRE is challenged by several
unique circumstances. It is axiomatic then, that the success of such a vital research-capacity building program
is dependent largely on the construct, dedication and management skills of the leadership team in the
Administrative Core. Hence, in INBRE V, we have assembled a consummate team of dedicated and skilled
administrative and scientific leaders to continue the trajectory of its past success and to accomplish the
following specific aims:
Specific Aim 1. Provide strong administrative leadership with oversight from three advisory committees.
Specific Aim 2. Manage the entirety of HI-INBRE including PATHway to Biomedical Careers for student
research, Developmental Research Project Program (DRPP) for investigator support and development, the
Data Science Core, and Evaluation activities.
Specific Aim 3. Expand HI-INBRE’s collaborative outreach to include programs beyond our Hawaiian borders